Functional consequences of stem and progenitor cell heterogeneity

OVERALL PROJECT SUMMARY
Cellular heterogeneity within the hematopoietic stem and progenitor cell (HSPC) pool is an increasingly
recognized aspect of normal hematopoiesis. Variability among individual cell clones contributes to these
heterogenous cellular states driving diversity of functional outcomes. Each clone bears differences across these
functional attributes, which is scripted by the epigenome of each cell. Here, we propose that distinctive clone-
specific features are particularly relevant to genetic clonal mutations. Specifically, the cellular and epigenetic
state of the clone in which a mutation occurs (the clone-of-origin) will alter cellular outcomes. Further, we
hypothesize that clonal diversity may contribute to the highly variable penetrance of a disease phenotype in the
context of clonal hematopoiesis (CH). We have assembled four teams of hematopoiesis experts and a pioneering
investigator in defining gene regulatory networks utilizing single-cell genomics to address this hypothesis. Using
a variety of models, we have evaluated the most common mutations in CH affecting Tet2, Dnmt3a2 and Asxl1.
Our motivating hypothesis and these preliminary studies support three focused areas of investigation: 1.
Epigenetic states poise the clone-of-origin for transformation by CH mutations, sensitizing cells for clonal
dominance; 2. Clones bearing a genetic mutation will exhibit divergent responses to exogenous stimuli further
enabling clonal dominance; 3. Metabolic adaptation frequently occur in dominant clones rendering them
vulnerable to metabolic drugs to reduce clonal burden. Collectively, these studies will provide a detailed
assessment of how hematopoietic clones become dominant, whether molecular signatures can be used to
predict clonal behavior in the setting of CH and whether low intensity, metabolism focused strategies can be
developed to impair competitively advantaged clones.

Public health relevance
OVERALL PROJECT NARRATIVE Blood cell production is the result of distinctive, heterogeneous individual primitive cells collectively generating mature cell offspring and when one of those primitive cells acquires a mutation, we propose that how it will behave depends on features present in the cell of origin and how the mutation affects cell signaling. Specific molecular features of the mutant clone may then provide predictive information about the pathogenic potential of a clone. Further, the metabolic alterations accompanying modified cell behavior can reveal exploitable vulnerabilities to guide testable, low intensity approaches to reducing clonal burden.